Mechanisms underlying Tip60 HAT action in neuroprotection of cognitive function

ABSTRACT
Alzheimer’s disease (AD) is a debilitating progressive neurodegenerative disorder (ND) hallmarked by
initial mild cognitive impairment (MCI) followed by dementia. The severity of AD progression is dependent upon
the complex interplay between genetics, age, and environmental factors orchestrated in large part, by epigenetic
histone acetylation (HA) mediated gene regulatory mechanisms. HA homoeostasis in the brain is maintained by
antagonizing histone acetyltransferase (HAT) and histone deacetyltransferase (HDAC) enzymes that generate
and erase cognition-linked histone acetylation marks, respectively. Reduced HA levels in the brain cause
chromatin packaging alterations in neurons, with concomitant transcriptional dysregulation that is a key initial step
in AD etiology. Nevertheless, the specific HATs that generate these distinct neuroepigenomic acetylation
signatures in the brain, and thus serve as causative agents underlying memory impairing HA alterations in AD,
remain largely unknown. Our laboratory has a long-standing interest in the HAT Tip60 as an epigenetic mediator
of neural transcriptional regulatory responses in cognition and AD. We generated a robust APP;Tip60 Drosophila
model system that enables us to modulate Tip60 HAT levels in neural circuits of choice under AD amyloid
precursor protein (APP) neurodegenerative conditions, in vivo. Its use led to a compendium of published studies
that establish a central role for Tip60 HAT mediated chromatin dynamics in cognitive function and
neuroprotection in AD. During this funding period, we also made several separate and striking discoveries
regarding alternative novel cellular mechanisms for Tip60 in mediating neuronal gene control that are disrupted in
AD. These include: (1) experience-dependent (ED) Tip60 nucleocytoplasmic transport (NCT) and (2) a novel
RNA-binding function for Tip60. The overarching goal of this proposal is to elucidate these new Tip60 functions,
as well as generate novel Tip60 specific therapeutic compounds, to deepen our understanding of Tip60’s unique
roles in nervous system biology and AD neuroprotection. To achieve this research goal, our team combines
expertise in the unique but complementing areas of Tip60 function in cognition and AD (Elefant, PI),
neuroepigenetics in RNA splicing (Heller, CoI) and novel drug discovery (Kortegare, CoI) to propose the following
specific aims: In Aim 1 we functionally assess Tip60 nucleocytoplasmic transport (NCT) in neuronal experience-
dependent gene control. In Aim 2 we dissect a novel bi-level neuronal function for Tip60 at the chromatin and
RNA splicing level in †he brain. In Aim 3 we will generate novel Tip60 based therapeutic compounds to identify
cognitive benefits of pharmacologically enhancing human Tip60’s HAT activity. Successful completion of this
project will uncover novel molecular pathways, targets and early biomarkers to treat AD and generate a specific
Tip60 HAT activator compound with AD neuroprotection capabilities.

Public health relevance
NARRATIVE Impairment of epigenetic gene control mechanisms in the brain involving reduced histone acetylation causes significant cognitive impairment that is a debilitating hallmark of Alzheimer’s disease (AD), yet little is known about the histone acetyltransferases (HATs) that generate these neuroepigenetic marks. Under this award, we established a central role for Tip60 HAT mediated chromatin dynamics in cognitive function and neuroprotection of a wide variety of specific neuronal processes impaired in AD. The findings from this renewal proposal will identify novel Tip60 mediated molecular pathways, targets, and early biomarkers to treat AD, as well as generate a specific Tip60 HAT activator compound with AD neuroprotection capabilities.